Development of small molecule inhibitors of ULK1

Several types of cancers, like pancreatic cancer, have been shown to be particularly dependent on autophagy for growth and survival. This project aims to develop potent, selective and bioavailable small molecule inhibitors of ULK1, an enzyme that initiates autophagy, to enable translation of the hypothesis: autophagy inhibition via ULK1 is a valid therapeutic approach for pancreatic cancer. During this period, the collaborative team performed hit-to-lead optimization to develop a potent, selective ULK1 inhibitor. Molecular docking models were also utilized to help engineer selectivity.